A Stem Cell Based Exosomal Vaccine for the Prevention of Cancer

PROJECT SUMMARY/ABSTRACT
Lung cancer is a prevalent disease and consume many lives every year. Disease relapse, invasion and
metastases are the main causes of death. Recent discoveries provide compelling evidence that at least some
types of cancer are initiated and maintained by a small population of malignant cells called cancer-initiating
stem cells (CICs). Relapse, invasion, and metastases are explained by the fact that CICs have a different
biology than all the other tumor cells and, importantly, are resistant to chemotherapies and radiation. Lung
CICs have been shown to represent about 1–15% of all tumor cells and can form tumors with injections as low
as 100 cells. Evidence from published studies have demonstrated that human, as well as rodent, cancers
contain populations of cells that express embryonic stem (ES) cell antigens. Cells containing these proteins
also express markers used to identify lung CICs; therefore, we hypothesized that ES cells and CICs share
several common molecular traits. To test this hypothesis, we vaccinated mice with exosomes derived from ES
cells expressing GM-CSF and investigated whether an anti-tumor immune response was elicited. We
discovered that ES cell-derived exosome-based vaccination strategy (ES-exo vaccine) is very effective in
preventing both implantable and carcinogen-induced lung adenocarcinoma development without any
detectable toxicity or signs of autoimmunity. Recently published results from our laboratory reveal that
splenocytes from ES cell-immunized mice are preferentially cytotoxic to lung CICs. Experiments proposed in
this application seek to expand these novel findings to convincingly demonstrate that ES-exo vaccine
immunize against lung cancer-associated CICs and that anti-CIC immunity is responsible for preventing lung
adenocarcinoma development. The anti-tumor activities of ES-exo vaccine as well as their immunostimulatory
properties will be investigated in in vitro and in vivo lung cancer mouse models. Experiments proposed in this
study will address the translational potential of our novel ES-exo vaccine as a cell-free prophylactic vaccine
modality in implantable, transgenic and xenograft mouse models of lung cancer. One of the major goals of this
application is to identify tumor antigens important for anti-lung cancer efficacy of ES-exo vaccine using a
proteomics-based screening methodology. To fulfill the stated objectives, the following aims are proposed: 1)
Investigate whether lung cancer-initiating cells are targets of ES cell-derived exosomes (ES-exo) vaccination-
induced anti-tumor immunity, and 2) Evaluate the translational potential of ES cell-derived exosomes (ES-exo)
as a novel cell-free vaccine for lung cancer. Our proposed study will provide important insights towards
developing a safe prophylactic vaccine for lung cancer onset and/or recurrence.

Public health relevance
Project Narrative Lung cancer patients remain at elevated risk for relapse following conventional treatment and recent studies of lung cancer biology provide compelling evidence that lung cancer is initiated by a small population of malignant cells called cancer-initiating cells (CICs); currently available cancer treatments may be ineffective against lung CICs. Our preliminary work using a vaccine consisting of exosomes derived from mouse embryonic stem cells (ES-exo vaccine) has provided validation that immunization with ES-exo vaccine prevents lung cancers in mice and our goal in this proposal is to investigate whether our novel cell-free ES-exo vaccine is effective in depleting lung CICs and preventing lung cancer onset and recurrence. Such a cancer vaccine will reduce health care costs and loss of life from a disease that is now a major health problem worldwide.